Graduate Training Grant in Genetics

SUMMARY/ABSTRACT
This application requests funding to support eight predoctoral students in the University of Oregon’s Genetics
Training Program (GTP). The students will train with one of 27 faculty mentors whose expertise collectively span
the subdisciplines of molecular, developmental, and evolutionary genetics. The mission of the GTP is to provide
PhD students with rigorous, well-rounded, and individualized training as geneticists that enables them to develop
their own scientific identities and pursue fulfilling careers in diverse scientific professions. The cohort of trainees
will share required coursework in foundational genetics, biostatistics, computer programming, and responsible
conduct of research. Trainees will conduct mentored research and individualized courses of study to deepen
their domain knowledge and grow their identities as scientific experts. Through a Career Development Program,
trainees will develop an understanding of the landscape of career opportunities available to them and will
examine their own talents and passions to identify career trajectories of interest. As members of a learning
community that values honesty, transparency, and rigor, our trainees develop into responsible scientific leaders.
The programmatic goals of the GTP are to: 1) Train graduate students to be fluent in foundational genetic
concepts, modern experimental techniques, and quantitative analytical approaches, enabling them to make
scientific discoveries that advance the field of genetics; 2) Prepare graduate students to be independent
professionals with the knowledge and skills to pursue fulfilling careers within the biomedical research enterprise
that build on their foundational knowledge of genetics; 3) Empower graduate students to be conscientious
citizens of the scientific community who uphold high standards of scientific rigor and reproducibility, safe
practices, and ethical conduct, and who shoulder the responsibility of communicating genetic concepts to the lay
public. We propose a robust evaluation framework to assess the effectiveness of our training activities in
achieving these goals and to implement programmatic changes to best serve the training needs of a diverse
cohort of students. The impacts of this program will be to advance new knowledge in genetics, contribute to a
diverse and productive research workforce, and promote a culture of ethical, responsible, and trustworthy
science.

Public health relevance
NARRATIVE The University of Oregon Genetics Training Program will train a cohort of PhD students in foundational genetic concepts and quantitative analytical approaches, provide them with skills to pursue fulfilling careers in biomedicine, and prepare them to be conscientious scientific leaders. This program will advance new knowledge in genetics, contribute to a diverse and productive research workforce, and promote a culture of ethical, responsible, and trustworthy science.